High-Dimensional Immune Monitoring of NCI-Supported Immunotherapy Trials

SUMMARY
Defining who is likely to respond to cancer immunotherapy and who may not benefit, due to primary/secondary
resistance or adverse events, is of critical interest for improving immuno-oncology (IO) treatments. Most clinical
trials of novel combinations either fail to include any support for complex correlative biomarker discovery, often
due to costs of specimen collection and assays, or are performed in an idiosyncratic manner, making non-
standardized data difficult to integrate as part of a larger repository. There is a need to go beyond just PD-L1
tissue expression and tumor mutation burden as FDA-approved yet imperfect predictors of immune checkpoint
blockade, by generating high-dimensional datasets that characterize the tumor immune microenvironment,
systemic circulating immune and proteomic markers from blood, and host-level immune fitness information
(microbiome). The Cancer Immune Monitoring and Analysis Centers, Cancer Immunologic Data Commons, and
Partnership for Accelerating Cancer Therapies (CIMAC-CIDC-PACT) is a Cancer Moonshot-funded network that
brings together laboratory, clinical, and computational scientists, administrators, and regulatory specialists from
four institutions, Icahn School of Medicine at Mount Sinai (ISMMS), MD Anderson Cancer Center (MDACC),
Dana-Farber Cancer Institute (DFCI), and Stanford University. Our unprecedented, coordinated effort to conduct
IO clinical trial correlative studies and define new candidate biomarkers to improve immunotherapy had resulted
in 37 clinical trials selected in the first funding period, with ongoing datasets resulted for 17 of them. This was
achieved using rigorously assessed SOPs and processes from trial selection to data sharing. We propose to
continue and expand these efforts as follows: A set of well-established, harmonized, high-dimensional tumor and
blood-based assays will be applied to all newly selected trials, with the aim of evaluating and validating novel
biomarker of treatment, clinical response, and/or adverse events (Aim 1). To spur innovation and increase
granularity of our understanding of mechanism of action, high-tech yet validated single cell and spatial
transcriptomic technologies as well as other omics will be proposed in exceptional patients for unbiased
phenotyping, tissue composition, architectural organization, and immune profiling (Aim 2). The resulting unified
data repository will be mined to define multi-omic and cross-trial markers, through biostatistical and
computational innovative design to integrate datasets from various assays into higher analytical archetypes
across studies (Aim 3). Together, our network is at the forefront of immune monitoring standards, by balancing
innovation with reproducibility, to comprehensively assess biomarkers and strive for precision cancer treatment.
We are poised to create an unparalleled resource of harmonized, clinically annotated datasets shared with the
public that will establish best practice guidelines with the research community. Through rigorous implementation
of state-of-the-art, cross-compared platforms, the CIMAC-CIDC initiative aims to accelerate identification of
clinically actionable biomarkers of response, resistance, and adverse events, and define mechanisms at play.

Public health relevance
NARRATIVE Through rigorous implementation of state-of-the-art, cross-compared technological platforms, we aim to accelerate identification of clinically actionable biomarkers of response, resistance, and adverse events, and define mechanisms at play to guide and improve novel NCI-supported cancer immunotherapy clinical trials.